SPAK inhibitor ZT-1a for ischemic stroke therapy

PROJECT ABSTRACT
Stroke remains as the 5th leading cause of death and
long-term adult disability in the USA because only ~15%
patients can
benefit from current standard therapies (
tissue plasminogen activator and endovascular
recanalization) due to their short therapeutic windows. Therefore, identification of novel stroke therapeutic targets
for neuroprotective drugs remains to be an unmet urgent need. Hypertension is the most significant risk factor
for stroke epidemics and angiotensin II (Ang II)-induced neurogenic hypertension is associated with worsened
ischemic brain damage. However, the clinical trial studies show no benefits of post-stroke blood pressure (BP)-
lowering treatment in the acute stage of ischemic stroke on improvement of the risk of death or disability because
it hinders cerebral perfusion. These findings challenge us to develop a novel strategy to block the AngII -mediated
detrimental effects in the ischemic brains without lowering BP and cerebral perfusion.
The serine-threonine WNK kinase family [with no lysine (K)], and its two downstream kinases SPAK (the
STE20/SPS1-related proline/alanine-rich kinase) and OSR1 (oxidative stress-responsive kinase 1) activate
multiple ion transporters and channels via protein phosphorylation. Na+-K+-2Cl- cotransporter isoform 1 (NKCC1)
is one of the major substrates of the WNK-SPAK/OSR1 kinases. Stimulation of
the
WNK-SPAK kinases
increased brain NKCC1 activity via protein phosphorylation and led to ischemic cell damage through NKCC1-
mediated Na+ and Cl- overload, cytotoxic edema and excitotoxicity. Our pilot study reveals that Ang II-induced
hypertensive mice exhibited 2-5 fold increase in the WNK-SPAK-NKCC1 protein complex expression in ischemic
brains, which was accompanied with worsened outcomes in infarct, edema, and neurological deficit in the
permanent middle cerebral artery occlusion model (pdMCAO). Post-stroke administration of a novel, non-ATP
competitive, selective SPAK inhibitor ZT-1a in these mice significantly reduced infarction and edema, and
improved neurological function recovery. However, how Ang II signaling pathway regulates WNK-SPAK-NKCC1
protein complex expression and efficacy of ZT-1a in reducing ischemic brain injury in the Ang II-induced
hypertensive mice remains unknown. We hypothesize that (1) Ang II stimulates Ang II receptor subtype 1 (AT1R)-
NF-κB cascade which leads to upregulation of WNK-SPAK-NKCC1 signaling complex after stroke; (2) elevated
WNK-SPAK-NKCC1 signaling directly contributes to the worsened ischemic neuronal damage and neurological
deficits; (3) post-stroke administration of the novel SPAK kinase inhibitor ZT-1a reduces ischemic brain damage
by preventing excessive activation of brain SPAK-NKCC1 signaling. These hypotheses will be tested in three
specific aims. In summary, we investigate that Ang II-induced hypertension comorbidity causes worsened
ischemic stroke outcome in part via stimulating the WNK-SPAK-NKCC1 signaling pathway in the CNS.
Completion of this study will enable us to gain new knowledge on whether targeting brain WNK-SPAK-NKCC1
signaling pathway will improve outcomes of ischemic stroke patients with comorbid hypertension.

Public health relevance
PROJECT NARRATIVE Stroke remains as the 5th leading cause of death and long-term adult disability in the USA. Moreover, hypertension and pre-hypertension are common in active US military personnel. Post-traumatic stress disorder is associated with different cardiovascular and cerebrovascular diseases in older veterans, including hypertension and ischemic stroke. This proposal is to understand cellular mechanisms underlying worsened ischemic stroke in hypertensive brains and to develop a novel therapeutic strategy for ischemic stroke with comorbid hypertension.